Measuring Ocular Pulse Amplitude with Fixed Force Applanation on Normotensive and Hypertensive Eyes

PROJECT SUMMARY/ABSTRACT
The measurement of intraocular pressure (IOP) is an integral part of the standard eye exam and elevated IOP
is the greatest risk factor for the development of glaucoma, the most common cause of irreversible blindness.
While the measurement of IOP, called tonometry, is frequently represented as a single number, the IOP is quite
dynamic with pulsations due to the cardiac cycle: the IOP peaks during systole and troughs during diastole. The
difference between the systolic and diastolic IOP is called the ocular pulse amplitude (OPA). Clinicians have
long been aware of these ocular pulsations and the presence of these pulsations can make it difficult to measure
the IOP: a large OPA is associated with significant IOP measurement variability. Fundamentally, the historical
method of using a single, snapshot IOP to represent such a dynamic element, results in greater variability than
desired and ignores much of the physiology of IOP and its effect on the eye. Prior studies have reported reduced
OPA in eyes with glaucoma compared with controls and that reduced OPA was associated with worse glaucoma
severity and a higher risk for glaucoma progression. Reduced OPA has been observed in biopsy-proven, giant
cell artieritis, exudative age-related macular degeneration and diabetic retinopathy. While there are many
preliminary studies that suggest the importance of OPA in the health of the eye, further study and has been
hampered by the lack of devices to measure OPA. The rationale for this project is to develop a novel and
validated method for measuring the OPA. This objective will be achieved by pursuing two specific aims: 1)
validate applanation-based OPA measurements on nonhuman primates implanted with an IOP telemetry system
in normotensive and hypertensive eyes; and 2) assess repeatability and reproducibility of OPA measurements
in normotensive and hypertensive eyes. Under the first aim, the algorithm for two previously developed
applanation-based tonometers will be modified to allow calculation of the OPA. Measurements with both devices
will be acquired on implanted non-human primates and the device measurements will be compared to the
telemetrically recorded values. Following algorithm optimization, a repeatability study with both devices will be
conducted on normal and hypertensive eyes in the implanted nonhuman primates. Under the second aim, the
previously optimized algorithm will be used first in a pilot study to assess proper performance in humans, followed
by a study to assess the repeatability and reproducibility of both devices in normal and hypertensive human
eyes. The proposed research is technically innovative because it proposes a novel technique for measuring the
OPA using applanation that will be uniquely validated against manometrically-derived, ground truth IOP and OPA
measurements. This innovation improves clinical care by improving reliability and accuracy of tonometry and
opens new research horizons to allow improved understanding of the role of OPA in normal and abnormal ocular
physiology.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it centers on developing a new method for measuring the ocular pulse amplitude (OPA) of the eye, a long-observed but poorly characterized physiologic feature of the eye. Prior research suggests that reduced OPA may be associated with glaucoma development and progression but further study has been limited due to the paucity of tools available to measure OPA. A novel method for monitoring the OPA could facilitate the diagnosis and management of glaucoma to reduce the risk of glaucoma related vision loss, which is consistent with the mission to reduce illness and disability.